Function of the Stem Cell Transcription Factor SOX2 in Prostatic Enlargement

Project Summary/Abstract:
Unlike many organs that undergo age-related degeneration, the prostate gland undergoes age-
related enlargement leading to significant health complications in the majority of men over 60
years old. Increasing evidence indicates a central role for prostate stem/progenitor cells and
abnormal activation of prostate regeneration pathways leading to prostate enlargement.
Current treatment approaches for prostatic enlargement primarily revolve around therapies
targeting the androgen receptor (AR), which can partially alleviate symptoms but do not achieve
permanent disease remission. Our laboratory recently determined that the important stem cell
factor SOX2 is an important stem/progenitor and survival factor during prostate development
and regeneration. SOX2 is a transcription factor that is essential for maintaining survival and
pluripotency of embryonic and many adult stem cells, and canonically interacts with OCT4 to
promote stem cell gene expression and repress differentiation. This proposal builds upon
our work demonstrating an important and novel non-stem cell and prostate-specific
function for SOX2 in the prostate, whereby SOX2 promotes resistance to AR-targeted
therapies and expansion of stem/progenitor cells to promote prostate enlargement.
However, there remain significant gaps in our understanding of the mechanistic role of SOX2 in
prostate enlargement; filling such knowledge gaps has a high potential to functionally implicate
SOX2 and SOX2-target genes as new therapeutic targets to prevent and treat age-related
prostate enlargement. The long-term goal of this project is to identify signaling pathways
regulated by SOX2 in prostate epithelial cells that can be targeted to prevent and therapeutically
treat prostate enlargement. The objective is to define how SOX2 promotes the survival of
multipotent prostate epithelial cells and contributes to prostate stem cell expansion glandular
enlargement and begin testing novel strategies to deplete prostate progenitor cell populations.
Our central hypothesis is that the quantity of SOX2-positive prostate cells increases during
aging, and SOX2 enables resistance to AR-targeted therapies, thereby promoting prostate
enlargement.

Public health relevance
Project Narrative: Prostatic enlargement continues to be a significant and incurable health problem that will only become more prevalent as life expectancy increases. Thus, there is a dire need for alternative therapies to induce and maintain permanent disease remission. The objective of this proposal is to define the mechanism of how SOX2 maintains multi-potent progenitor cells and promotes prostate enlargement.